A Relaxin-loaded Hydrogel for the Treatment of Hypertrophic Scars

PROJECT SUMMARY/ABSTRACT
*This proposal describes an innovative treatment for hypertrophic scars that prevents and treats pathologic fi-
brogenesis after dermal injury. Hypertrophic scars affect tens of millions of people each year, including over 50%
of surgical patients and 90% of deep partial thickness and full-thickness burn injury patents. Current non-surgical
treatments (e.g., laser/cryotherapy, cytotoxic drugs, corticosteroids) are painful and limited in their scope and
efficacy, while surgical interventions are invasive, expensive, and may cause recurring hypertrophic scar for-
mation. There is currently no optimal treatment for hypertrophic scars, as these options do not target the under-
lying pathology of scar development. We propose the use of human relaxin-2 (RLX-2), an endogenous 6-kDa
antifibrotic peptide hormone, as a novel protein therapeutic for the treatment of hypertrophic scars that targets
the fibrotic build-up of extracellular matrix (ECM) proteins in abnormal scar development. Importantly, we employ
a RLX-2-loaded in situ polymerizing hydrogel, whereby RLX-2 is uniquely linked to the hydrogel and subse-
quently released in its native form, to achieve sustained and localized delivery. Additionally, we describe detailed
mechanism-of-action (MOA) studies to examine RLX-2 as a therapeutic protein to reduce fibrosis in dermal
fibroblasts through: 1) impeding myofibroblast differentiation and ECM deposition by inhibiting the TGF-β1 path-
way; 2) upregulating matrix metalloproteinases that degrade collagen; and 3) downregulating tissue inhibitors of
metalloproteinases. We hypothesize that the sustained release of RLX-2 from a locally applied hydrogel
to deep dermal wounds will promote proper wound healing, reduce excessive collagen levels, and alle-
viate scar size and appearance (i.e., prevent and treat hypertrophic scars). Importantly, preliminary data
support the proposed studies, well-characterized materials and rigorous experimental designs are established,
and essential cross-disciplinary collaborations and expertise are in place to address the hypothesis. The specific
aims of this five-year proposal are as follows. Aim 1 determines the MOA of RLX-2 in vitro in a 3D organotypic
skin model and in ex vivo patient biopsy explants to provide knowledge on the molecular signaling behind RLX-
2’s ability to reduce fibrotic scarring. Aim 2 develops a RLX-2-loaded hydrogel for localized and sustained topical
release of RLX-2. We will use our newly discovered method that harnesses intein chemistry to enable soluble
expression and purification of recombinant RLX-2 functionalized to efficiently conjugate to the hydrogel and then
release unaltered to the skin. Aim 3 assesses the pharmacokinetics, biodistribution, and efficacy of the RLX-2-
loaded hydrogel in an in vivo swine model of hypertrophic scarring, along with live tissue imaging methods to
examine RLX-2 effects on wound healing dynamics and reduction of fibrotic scarring. Together, these aims will
demonstrate the efficacy of a locally delivered RLX-2-based system to reduce aberrant scarring and will elucidate
the MOA underlying this activity. Furthermore, we will establish a unique protein purification-functionalization
strategy which will be broadly applicable to the sustained delivery of other therapeutic proteins.

Public health relevance
PROJECT NARRATIVE Hypertrophic scars arise in over 50% of all surgical procedures and 90% of burn injuries, and are physically uncomfortable and painful, as well as inflict psychological damage due to their negative cosmetic appearances. Current treatment options are limited in their scope and efficacy, as they do not target the underlying cause of scar development: a dysregulated wound healing response. Here, the sustained and localized delivery of the natural antifibrotic peptide hormone, relaxin-2, via a hydrogel, is described as a novel solution to treat both the underlying etiology and symptomatic presentation of hypertrophic scars.